Michigan Integrative Musculoskeletal Health Core Center (Overall Application)

Michigan Integrative Musculoskeletal Health Core Center - Overview
Project Summary
Musculoskeletal disorders remain an enormous public healthcare problem, accounting for more than fifty percent
of chronic conditions in developed countries. The current financial landscape not only challenges investigator-
led scientific programs, but particularly threatens collaborative research because lack of flexibility in individual
budgets restricts resources and ability to share valuable techniques with our scientific neighbors. The Michigan
Integrative Musculoskeletal Health Core Center (MiMHC) enables vertically integrated, multi-scale
musculoskeletal science from molecular and omic-level mechanisms to organismal function and clinical
outcomes by increasing access to critical, specialized resources and expertise that are fundamental to the
musculoskeletal research programs of 90 Center investigators. The MiMHC is structured to be consistent with
initiatives at the University of Michigan aimed at promoting collaborations across disciplines and between basic
scientists and clinicians to promote health by better understanding disease and injury mechanisms. The MiMHC
not only enhances the capabilities of a group of outstanding musculoskeletal researchers but also leverages
their collective talent through an Enrichment Program that promotes novel and emerging musculoskeletal
research in cross-tissue interactions and sex-specific differences throughout the life course. An outreach
program creates a rich community of musculoskeletal scientists through a novel monthly seminar series that
builds on existing momentum toward accelerating discussion, critical thinking, research rigor and reproducibility,
and innovation. To accomplish these goals, an Administrative Core will oversee core operations and three
Resource Cores to provide Structure, Composition, and Histology services, Functional assessment services,
and Integrative Data Analytics services to all members of the MiMHC research community. The Resource Cores
are structured to facilitate hierarchically mechanistic studies from the molecular and omic-levels through the
organ-level and to the clinical setting. Access to the Resource Cores has been and will continue to be financially
and scientifically impactful to Center investigators by centralizing core technologies and by providing access to
Core Directors who are experts in their field and who will provide guidance on the best choice of technologies,
experimental design, and data interpretation. The UM environment is ideal for continuing to build a strong
research community and to sustain an innovative, collaborative venture aimed at advancing understanding of
musculoskeletal health and disease and to conduct science highly relevant to the NIAMS mission.

Public health relevance
Narrative The Michigan Integrative Musculoskeletal Health Core Center will advance healthcare by providing outstanding, state-of-the-art resources and training to enable, enhance, accelerate, and expand the high quality cutting edge research programs of our large well-funded research community. The enrichment program promotes community and inter-disciplinary scholarship to advance novel and emerging science focused on sex specific differences and interactions among musculoskeletal tissues.